New Strategies and Reactions for the α-C–H Functionalization and Hydrofunctionalization of Carbon–Carbon Multiple Bonds

Project Summary
The objective of this project is the development of a series of new organic methods through nontraditional
approaches for the activation of the π-bonds of alkynes and alkenes, along with their associated propargylic
and allylic positions. These methods greatly increase the versatility of these functional groups, providing
streamlined access to substructures and motifs that regularly occur in compounds of relevance to biomedical
research. In particular, in the first research area, we develop iron-based catalysts for the catalytic generation
of nucleophilic propargyl and allyl equivalents. The production of these catalytic intermediates will allow for the
formation of C–C and C–X bonds in a variety of synthetically useful and biomedically relevant contexts. In the
second research area, we develop methods that take advantage of a newly discovered series for reagents and
conditions for the generation of electron-deficient vinyl intermediates from alkynes. These reagents and
conditions enable the development of vinyl electrophile chemistry in complex, late-stage contexts for the
synthesis of heterocyclic derivatives and trisubstituted olefins in a stereodefined manner. These new methods
will allow for drug discovery and development efforts to take place in an accelerated manner to exert a positive
impact on public health.

Public health relevance
Project narrative The preparation of small organic molecules in efficient, concise, and convenient manner is critical for the discovery, development, and eventual production of pharmaceutical agents and other bioactive molecules for biomedical research. In this proposal, new organic reaction methodologies that employ simple and readily available alkene and alkyne containing starting materials are proposed for the expedited synthesis of molecules with direct relevance to the preparation of bioactive molecules. Thus, the successful development of these strategies will have a substantially positive impact on the achievement of public health goals.